Understanding the progression of hearing loss in an endolymphatic hydrops model

remains unknown. Studies examining the temporal bone of patients affected by MD have revealed a
condition called endolymphatic hydrops, an expansion of the scala media suggesting a disruption in the
balance of fluids within the inner ear. Endolymph, a crucial fluid within the membranous labyrinth of the
inner ear, plays a pivotal role in maintaining both hearing and balance. Despite its significance, our
understanding of how this fluid is regulated remains limited. Considering the importance of fluid
homeostasis in the inner ear, the goal of our research is to understand the formation of endolymphatic
hydrops and the consequences on neuronal dysfunction.
In this research, we will investigate inner ear dysfunction in an animal model of endolymphatic hydrops.
Aim 1: We will correlate hearing and balance thresholds with the ionic and protein composition of
endolymph and perilymph.
Aim 2: We will test if there is degradation of the blood endolymph barrier during development of
endolymphatic hydrops.
Aim 3: We will conduct transcriptomic analysis on the hydropic neurons to better understand the cause of
neuronal dysfunction during the development of endolymphatic hydrops.
These studies are essential for comprehending potential mechanisms underlying disruptions in inner ear
homeostasis and the development of conditions like MD. This understanding will be essential in developing
targeted therapies for MD and related conditions.